Complex pitch perception in complex environments

Pitch plays a fundamental role in auditory and speech perception. In music it defines melody and harmony; in
speech it carries prosodic and (in tone languages) lexical information; and in everyday complex acoustic
environments it plays a critical role in helping us to segregate and hear out important sounds against a
background of other sounds. Despite its importance, fundamental questions surrounding how pitch is perceived
and neurally encoded remain unanswered. There is, for instance, no consensus on how and why pitch accuracy
degrades with hearing loss and/or age. Similarly, despite cochlear implants’ many successes, pitch remains very
poorly conveyed for reasons that remain a matter of debate. This project combines behavioral studies in normal-
hearing and hearing-impaired adults across the lifespan (Aim 1), behavioral and EEG studies in infants (Aim 2),
and high-resolution neuroimaging (fMRI) studies in adults (Aim 3) with computational modeling to answer a
cohesive set of fundamental questions on how pitch is perceived and represented. These questions include
whether peripheral or more central (experienced-based) factors lead to the dominance of low-numbered
harmonics in everyday pitch perception (Aims 1 and 2), and whether the interactions between the perceptual
dimensions of pitch (based on fundamental frequency) and brightness (based on spectral centroid) follow a
developmental trajectory that is also reflected in their cortical representations (Aims 2 and 3). The first two
experiments of Aim 1 (Exp. 1A/B) use individual differences to determine the effects of age and hearing loss on
the accuracy of pitch perception. They test the hypotheses that the sharp transition between good and poor pitch
discrimination as lower harmonics are progressively removed is due to the limits of auditory filtering, as
influenced by cochlear hearing loss, and that overall pitch fidelity across all conditions is degraded by age, as
expected from age-related cochlear synaptopathy. Aim 1’s third experiment (Exp. 1C) utilizes recent signal-
processing developments to test the role of harmonicity of either the target or interfering speech in the perceptual
segregation of competing talkers. Aim 2 uses a developmental approach to test whether properties that are
currently believed to be innate, including interference between pitch and brightness (Exp. 2A/B), and poor
accuracy at high harmonic numbers and/or frequencies (Exp. 2C/D), are in fact centrally mediated developmental
traits that emerge after extensive exposure to natural sounds. Finally, Aim 3 uses ultra-high-field (7T) fMRI to
determine whether the perceptual interference observed in adults between pitch and brightness is reflected by
interdependence of cortical tuning (Exp. 3A); whether cortical mapping of pitch and frequency is affected by the
context in which the tones are presented (Exp. 3B); and whether cortical correlates of pitch interval size and
direction can be observed (Exp. 3C). By improving our fundamental understanding of the neural coding and
perception of pitch, we will be better placed to improve its representation in people with hearing loss and cochlear
implants.

Public health relevance
PROJECT NARRATIVE This project investigates the perception and neural coding of pitch in infants, as well as in adults throughout the lifespan with normal and impaired hearing. Pitch plays a crucial role in music and speech perception, and in enabling us to hear out one voice in the presence of other competing sounds. An improved understanding of how pitch is coded should lead to better hearing aids and auditory implants, which will help people with hearing disabilities communicate more effectively.